Administrative and Coordination Core

PROJECT SUMMARY ADMINISTRATIVE (ADMIN) CORE
The Administration (ADMIN) Core of the Indiana University (IU)/Jackson Laboratory (JAX)/University of
Pittsburgh (PITT) Model Organism Development and Evaluation for Late-onset Alzheimer’s Disease Center
(IU/JAX/PITT MODEL-AD), led by ADMIN Head Dr. Bruce Lamb at IU with assistance from multiple
Principle Investigators (mPIs) Drs. Paul Territo and Adrian Oblak at IU, Drs. Greg Carter, Gareth Howell,
and Mike Sasner at JAX, Dr. Stacey Rizzo at PITT, and Dr. Anna Greenwood at Sage Bionetworks and
with the support of Program Co-Managers and full-time administrators at both IU and JAX, will oversee all
administrative and scientific functions of the Center. The ADMIN Core will execute these duties with
oversight from an External Advisory Board (EAB) comprising leading experts in the field and a Center
Steering Committee (CSC) comprising IU/JAX/PITT and UCI MODEL-AD Center PIs and NIH program
officials. The EAB will convene annually, the CSC monthly, and the entire MODEL-AD consortium monthly
to review progress and provide input and feedback (oral and written) to ensure that the Center (1) achieves
its mission, aims, milestones, and metrics; (2) coordinates efforts across the two MODEL-AD Centers; (3)
effectively deals with any unanticipated problems or concerns; and (4) adapts to likely experimental and
technical advances in the field. There will be biweekly ADMIN, BDMC, DMP, and PTC meetings and joint
BDMC/DMP meetings. These will be focused on issues unique to specific Cores/Projects while ensuring
maximal synergy among the various components of the IU/JAX/PITT MODEL-AD Center. Close interaction
will be fostered among the BDMC, PTC, and the DMP, thus facilitating timely discoveries while reducing
overall costs. One of the primary goals of the ADMIN Core will be to ensure that discoveries made in one
area of the Center will benefit the Center overall, leading to efficiencies in time and cost. Finally, the ADMIN
Core will also promote Center interactions and meetings with other ongoing research efforts in the
Alzheimer’s research community, including the NIA-supported ADRCs, the Alzheimer’s Disease
Neuroimaging Initiative (ADNI), the Alzheimer’s Disease Accelerating Medicine’s Partnership (AMP-AD),
and the Target Enablement to Accelerate Therapy Development for Alzheimer’s Disease (TREAT-AD)
consortium.
The Specific Aims of the IU/JAX/PITT MODEL-AD ADMIN Core are as follows:
1. Provide effective and efficient management, oversight, and evaluation of the IU/JAX/PITT
MODEL-AD Center and its interactions with the AD research community.
2. Ensure timely and successful completion of all Project and Core aims and milestones.
3. Facilitate interactions between and among the Bioinformatics and Data Management Core, the
Preclinical Testing Core, and the Disease Model Project.